Homeostatic Regulation of PIP2-Calcium Signaling

This is an administrative supplement application for purchasing a stage top incubator to replace the
malfunctioning enclosure-style incubator installed on the confocal-TIRF microscope system in the PI’s
lab more than 15 years ago. A functioning incubator that provides optimal temperature, CO2, and
humidity to keep cells healthy during imaging experiments is critical for the success of the parent
project that heavily relies on live-cell imaging assays to define mechanisms regulating PIP2
homeostasis by Nir2 protein at endoplasmic reticulum (ER)-plasma membrane (PM) junctions during
receptor-induced Ca2+ signaling. The purchase of a new stage top incubator system is urgently
needed to reinstate live cell imaging capability of proposed experiments crucial for the success of the
parent project. A new stage top incubator system will provide a consistent environment for cells to stay
healthy for high-quality and quantitative imaging results which is critical for the awarded project.

Public health relevance
This application for administrative supplemental grant is to request fund for purchasing a stage top incubator to enable long time-lapse measurements of dynamic signaling processes in living cells using the confocal-TIRF microscope system in the PI’s lab. This purchase is critical for getting consistent results for proposed research in the parent project.